Morphology Core

PROJECT SUMMARY – MORPHOLOGY CORE
The Morphology Core Facility provides instrumentation and technical expertise for the preparation, acquisition
and analysis of images of cells and tissues at both the light and electron microscopic level. Given the cost of
such instrumentation and the high level of technical expertise required to perform these investigational
techniques, this Core was established to ensure the availability of these techniques for Center members. In
recognition of the broad usefulness of this Core facility, the School of Medicine has partnered with the Liver
Center by making ongoing, major investments to ensure that the facility remains state-of-the-art. The
Morphology Core offers the following specific activities and services, plus associated training and technical
support: (1) confocal microscopy, (2) multiphoton microscopy, (3) super-resolution microscopy, (4) swept field
microscopy, (5) light sheet microscopy, (6) electron microscopy, (7) image analysis, and (8) other microscopy
tools, including widefield and brightfield microscopy and cryo-sectioning. More than two-thirds of the members
of the Liver Center used this core facility and the core was used in over one hundred forty publications during
the current award period, reflecting the continued usefulness and importance of this resource for the mission of
the Center.